PUFA partitioning into condensates as a new mechanism for gene regulation

SUMMARY: Understanding the mechanisms underlying the cardioprotective and other health benefits of
polyunsaturated fatty acids (PUFAs) is critical for providing sound nutritional advice. A major explanation for
how PUFAs mediate their effects is by altering gene expression. Through gene expression, specific PUFAs
reduce triglyceride levels and inflammation. Yet, we do not clearly understand the basis for the specificity of
some, but not other fatty acids in regulating gene expression. This is a major problem for fully understanding
the health implications of eating foods with complex mixtures of these different fatty acids.
One of the major transcription factor families that mediates the effect of PUFAs are the peroxisome proliferator-
activated receptors (PPARs). PUFAs have been found to bind to PPARs and to promoter their activation of
target gene transcription. However, there has been disagreement on the effective binding affinity of PUFAs for
PPARs and whether it is physiologically relevant. This has led to confusion over the role of PUFAs as PPAR
agonists. However, these studies assumed that PPAR is localized to the aqueous nucleoplasm and that they
interact with PUFAs in this environment. Instead, at least one PPAR protein, PPARγ, localizes to condensates,
which are membraneless organelles enriched in proteins and nucleic acids. We have recently shown that these
environments enrich multiple classes of lipids, including PUFAs. Additional analysis of our datasets has also
demonstrated that only specific fatty acids enrich in condensates and that this correlates with their number of
unsaturated bonds.
In this project, we will explore a new explanation for why specific PUFAs regulate PPARγ-mediated
transcription initiation more than others. Rather than different abilities to bind the PPARγ ligand binding
domain, the extent to which a specific PUFA species regulates PPARγ may be determined by its ability to
enrich in PPARγ condensates. Additionally, this novel form of regulation may specifically effect PPARγ-bound
genes in condensates, while not affecting other PPARγ-bound genes.
In Aim 1, we will determine if PPARγ agonists enrich in PPARγ-containing condensates. First, we will measure
the extent to which different PUFAs and other putative PPARγ agonists enrich in PPARγ condensates in vitro.
We will then determine whether a subset of PUFAs also enrich in cellular PPARγ-containing condensates using
super-resolution, lipid expansion microscopy. Finally, we will determine if transcription activation by PPARγ
agonists correlates with their ability to enrich in PPARγ condensates. In Aim 2, we will test whether the
condensate pool of PPARγ proteins are preferentially activated by PUFAs and other PPARγ agonists. We will
address this question by measuring co-activator binding to PPARγ after addition of different agonists, both in
vitro and in multiple cell-base assays. Together, these two aims will establish whether specific PUFAs
preferentially activate the condensate pool of PPARγ proteins.

Public health relevance
PROJECT NARRATIVE: Omega-3 and omega-6 fatty acids are examples of potent plant - and fish - derived dietary lipids that have pronounced benefits for cardiovascular health. Here we propose a new mechanism for the effects of these dietary lipids and supplements that involves their ability to efficiently enter into cellular structures called “condensates.” In this proposal, we explore how this property may account for this particular set of fatty acids’ previously unexplained positive effects on gene expression.